Diabetes Evaluation in TB Patients in Eswatini for Improving TB/HIV Care and Treatment (DETECT) Study

PROJECT SUMMARY
HIV, tuberculosis (TB), and diabetes mellitus (DM) are major causes of morbidity and mortality globally. DM and
prediabetes (preDM) are growing rapidly worldwide but 69% of persons living with DM in sub-Saharan Africa are
unaware they have DM. Persons living with HIV are more likely to have DM than those without HIV, and DM is
especially prevalent among newly diagnosed TB patients globally. Poorly controlled DM increases the risk of TB
and leads to suboptimal TB treatment outcomes. Diagnosing DM early in TB treatment and assessing the
adequacy of glycemic control are important. HIV, TB, and DM are all in the top 10 causes of mortality in Eswatini,
and DM prevalence in Eswatini is 6.6%; 36.1% of the population is overweight and 14.8% obese. With one of
the world’s most severe HIV and TB epidemics (HIV prevalence=27%, TB incidence=329 per 100,000, and 66%
of TB patients are HIV-positive), Eswatini is an optimal setting to evaluate what proportion of TB patients are on
the DM spectrum ([DMS], i.e., have DM or preDM), how their TB treatment outcomes compare to TB patients
without DMS, and whether they vary by HIV status.
The DETECT (Diabetes Evaluation in TB patients in Eswatini for improving TB/HIV Care and Treatment) study
will use mixed methods to assess DMS prevalence and incidence as well as TB treatment outcomes in TB
patients in Eswatini and explore the suitability of lifestyle management intervention strategies to facilitate TB
treatment success and glycemic control. We will screen all adult TB patients diagnosed and treated in Ministry
of Health facilities in the Manzini Region for DMS during the study period, and abstract TB treatment outcomes
from medical records. We will administer a quantitative survey regarding DMS risk factors and lifestyle
preferences to two measurement cohorts of TB patients with and without DMS and retest them for DMS at the
end of TB treatment. We will also conduct qualitative in-depth interviews with TB/DMS patients, healthcare
providers, and key informants to elicit insights on barriers to and facilitators of TB treatment success and glycemic
control in TB/DMS patients and assess feasibility and acceptability of potential lifestyle intervention components.
The study will leverage long-standing collaborations between ICAP, the Eswatini National TB Control, AIDS, and
Non-Communicable Diseases Programs, and a well-trained, highly productive team with substantial experience
in implementation science research in sub-Saharan Africa to inform the improvement of TB/DMS care in the
context of HIV infection in high TB and HIV burden settings. Following this study, in collaboration with the MOH
and based on the above results, we will develop a multicomponent, culturally-tailored behavioral intervention
strategy to support the improvement of TB outcomes and glycemic control in TB/DMS patients. The intervention
strategy’s effectiveness, cost-effectiveness, and acceptability will be tested in a future, larger trial.

Public health relevance
PROJECT NARRATIVE Diabetes mellitus (DM) increases the risk of suboptimal treatment outcomes among TB patients, underscoring the importance of diagnosing DM early in TB treatment and integrating DM services into TB/HIV care. However, the burden and impact of DM on TB patients in Eswatini are unknown. The DETECT study will use mixed methods to assess DM prevalence, incidence, and TB treatment outcomes in TB patients in Eswatini and explore the suitability of lifestyle management intervention components to facilitate TB treatment success and glycemic control in TB/DM patients.